Novel approaches to dissect the genetic susceptibilities to celiac disease

Abstract
Celiac disease (CeD) affects approximately 1% of the U.S. population. It is associated with several co-
morbidities, including osteoporosis, type 1 diabetes (T1DM), anemia, reduced quality of life, and
increased cancer risk. Currently, there is no approved drug to treat CeD, and the primary management
strategy—strict adherence to a gluten-free diet—is not always fully effective. Human genetics play a
critical role in CeD, as the presence of HLA-DQ2 or DQ8 is necessary for disease development, but
not sufficient on its own to cause it. Our aim is to identify additional genetic factors that influence the
clinical penetrance of HLA-DQ2 or DQ8. We recruited 51 families with multiple affected individuals and
conducted exome sequencing to create a familial CeD cohort. In addition, we utilized whole genome
sequencing data from 1,930 CeD patients enrolled in the All of Us research program (AoU-CeD cohort).
Our analysis of genomic data from these two cohorts has led to important discoveries and unexpected
insights. In this R03 grant, we propose to further explore the genetic risks for CeD using three innovative
approaches based on next-generation sequencing data. Our first aim is to identify functional variants
in linkage disequilibrium with the AH8.1 (A1:B8:C7:DR3:DQ2) haplotype, which includes the high-risk
HLA-DQ2.5 allele. The second aim focuses on gene burden testing and pathway analysis to identify
rare variants and evaluate their impacts on CeD. The third aim seeks to identify genetic risk factors for
CeD in patients with admixed African and American ancestry. Through this research, we hope to
uncover novel genetic factors that can enhance risk stratification and identify potential therapeutic
targets for patients from diverse ethnic and genetic backgrounds. These findings could significantly
improve genetic diagnosis and guide future therapeutic strategies for CeD.

Public health relevance
Project Narrative Celiac disease affects about 1% of the U.S. population, predominantly among individuals of European ancestry. Our research aims to identify genetic factors that influence CeD risk beyond the known HLA- DQ2 and DQ8 associations by focusing on three key objectives: identifying functional variants in linkage disequilibrium with the AH8.1 ancestry haplotype, using gene burden testing and pathway analysis to uncover rare variants that impact CeD, and investigating genetic risks in CeD patients with admixed African and American ancestry. These approaches will provide new insights into CeD risk stratification and potentially uncover therapeutic targets for more effective management.